Point of Care Technologies for Nutrition, Infection, and Cancer for Global Health (PORTENT)

Point of Care Technologies for Nutrition, Infection and Cancer for Global Health (PORTENT)
2.0 Administration Core
Abstract
The global nature of the PORTENT center requires a unique administrative core with deep experience in
international collaboration, research administration, clinical practice, needs assessment and training
and technology commercialization. With deeply established experience in biomedical technology
development, global health, international training, and center management Cornell University in partnership with
Columbia University and McGill University are uniquely positioned to establish and manage such an effort.
Through our prior capacity building efforts, we have established relationships with all the PORTENT clinical sites
– including IRBs - which will enable much more efficient and timely administration and execution of center
projects. The technical and clinical direction of the center will be guided by an External Advisory Board – who
will help set the overall direction of the center and support the final selection of new PoC projects – and a Needs
Assessment Advisory Board – that will establish an annual needs assessment consensus to support project
solicitation. Center expertise will also be supported by an extensive network of partner companies, governmental
and non-governmental organizations, and global health related academic programs.
Working in concert with the other cores, the primary focus of the Administration Core will be to (1) Effectively
employ the PORTENT’s clinical, technical, and other resources in support of the funded PoC projects, (2)
Administer annual Requests for Proposals to solicit new and evaluate current projects, and (3) Establish and
manage the advisory committees, (4) Ensure overall coordination between the three domestic partner sites and
four primary clinical sites, (5) Maintain the network of external partnerships and establish new ones, and (5)
Manage the day-to-day activities of the center including financial, human resources, administrative support and
conflict management.